INFLUENCE OF PERIODONTAL THERAPY ON METABOLIC AND IMMUNOLOGICAL CONTROL OF TID

This subproject is one of many research subprojects utilizing the resources provided by a Center grant funded by NIH/NCRR. The subproject and investigator (PI) may have received primary funding from another NIH source, and thus could be represented in other CRISP entries. The institution listed is for the Center, which is not necessarily the institution for the investigator. Diabetes mellitus affects >171 million people worldwide, with type II diabetes being the most prevalent, affecting 85-95% of the diabetic population. Despite conventional medical treatment, some diabetic patients do not seem to be able to reach desirable metabolic control. Studies have shown a correlation between chronic inflammatory periodontal diseases and diabetes, in which both diseases influence the progression and response to treatment of the other. Studies have demonstrated that mechanical periodontal treatment can improve the level of metabolic control in patients with diabetes. It is still not clear which periodontal treatment approach would best benefit the metabolic control of diabetic patients or the mechanisms of how this occurs. It is our hypothesis that successful treatment of periodontal disease in type II diabetic patients will positively affect their metabolic and immunological control. The aims of this study are: to determine the periodontal status of diabetic patients who do not respond well to medical treatment; to evaluate whether medicated diabetic patients, with undesirable HbA1c levels and concomitant periodontal disease, will show improvement in periodontal status, glycemic control, and inflammatory responses following routine, non-surgical periodontal treatments;and to determine if type II diabetes affects the expression of virulence factors of oral pathogens known to contribute to periodontal disease.